Signaling networks controlling organ growth and tissue patterning

Project Summary/Abstract
The overall goal of this application is to advance understanding of cellular signaling networks controlling
organism development. We will investigate three signaling systems that represent different regulatory
mechanisms but are united by a common theme: these pathways control key developmental processes of organ
growth and tissue patterning. Specifically, we will study signaling events downstream of the receptor tyrosine
kinase (RTK)/extracellular signal-regulated kinase (ERK) pathway, regulation of Hippo signaling, and the
functions of the kinase Minibrain/DYRK1A. We are using the advantages of the fruit fly Drosophila to investigate
these mechanisms, however the knowledge generated in these studies is relevant for human biology due to the
deep evolutionary conservation of the regulatory mechanisms and relevant molecules. Dysregulation of all three
pathways in humans results in diseases ranging from cancer to neurodevelopmental disorders. Our approach is
based on exciting preliminary data suggesting new avenues in the study of these pathways and relies on a
combination of biochemical methods such as affinity purification-mass spectrometry (AP-MS) and advanced
genetic and imaging assays. In Research Direction 1, we will investigate ERK-mediated downregulation of the
transcriptional repressor Capicua and define its network of corepressors and chromatin regulators. In Research
Direction 2, we will study two novel modes of regulation of Hippo signaling: one is centered on CG14767, an
uncharacterized membrane protein that is likely involved in endolysosomal regulation, and the second includes
Spenito (Nito), which is a component of RNA splicing and modification machinery that modulates Hippo signaling
in an unknown way, likely via interactions with other RNA binding proteins. In Research Direction 3, we will
elucidate the regulation of brain and epithelial development by the Minibrain/Rala signaling network that we
recently uncovered. The proposed research will establish general regulatory principles in these signaling
networks that converge to regulate organ growth and tissue patterning in development.

Public health relevance
Project Narrative This project will investigate general mechanisms of cell communication, or cell signaling, that are critical for proper growth of organs and tissues at embryonic and later developmental stages. Mutations in these pathways cause many human diseases, including Down syndrome, Alzheimer's disease, microcephaly, intellectual disability, and cancer. The primary experimental system is the fruit fly Drosophila melanogaster, in which these signaling pathways work in much the same way as they do in humans, and that offers many advantages for performing biochemical and genetic experiments.